Molecular Basis for cMyBP-C HCM variants

ABSTRACT
Hypertrophic cardiomyopathy (HCM) is a common disorder that affects 1 in 300 individuals and is characterized
by abnormal cardiac morphology and function leading to an increased risk of heart failure and sudden cardiac
death. HCM is often caused by inherited variants in genes that regulate force generation and contractile function
in cardiac myocytes. Mutations in the gene encoding cardiac myosin binding protein C (cMyBP-C) are the most
common, accounting for more than half of all known cases of inherited HCM. Mutations in MYBPC3 that result
in truncated proteins reduce sarcomeric expression of cMyBP-C, however, missense variants are typically
incorporated into the sarcomere and alter cMyBP-C function. The vast majority of cMyBP-C missense variants
are classified as variants of unknown significance as there is not enough information to accurately predict
whether patients with these variants will develop disease. A primary reason for our inability to predict cMyBP-C
variant pathogenicity is our poor understanding of cMyBP-C’s complex structure and function. cMyBP-C is a
large ~140kDa, 11-domain molecule that modulates contractile function through interactions with multiple binding
partners, though the precise molecular mechanisms that govern these interactions are yet to be determined.
Therefore, it is unclear how missense variants in different domains of the molecule that have specialized roles
affect contractile function and cause HCM. Therefore, the central goal of this proposal is to define the effects of
cMyBP-C missense variants on cardiac sarcomere molecular structure and function, and to link these
mechanisms to altered whole organ structure and function and development of HCM. To accomplish this goal
we have devised a comprehensive experimental plan that defines the consequences of cMyBP-C missense
variants from atom to whole animal levels. In Aim 1 we will utilize cryo-electron microscopy (cryo-EM) to solve
near-atomic structure of cMyBP-C variants. In Aim 2 we will elucidate the domain-specific effects of missense
variants on ligand binding, cross-bridge behavior, and myocardial force generation and relaxation. In Aim 3, we
will determine the in vivo effects of missense mutations on development and progression of cardiac hypertrophy,
and contractile and hemodynamic dysfunction. By integrating studies of cardiac sarcomere structure, cellular
biophysics, and in vivo function, we will uncover the mechanisms by which missense cMyBP-C variants cause
HCM, thereby, improving our ability to predict which variants are most likely to cause disease. We anticipate that
these studies will advance our understanding of fundamental processes that regulate cardiac contractile function,
which may motivate the development of novel therapies to treat cMyBP-C related cardiomyopathies.

Public health relevance
NARRATIVE Patients with hypertrophic cardiomyopathy due to genetic mutations in the contractile protein cardiac myosin binding protein C (cMyBP-C) are at an increased risk for developing severe heart failure, but developing effective treatments requires a better understanding of how these mutations affect cardiac muscle contraction and relaxation. To accomplish this goal, this project integrates experiments aimed at identifying how these mutations affect the structure and function of cMyBP-C in order to better understand how they will affect in vivo heart performance. The long-term impact is improved outcomes for patients with hypertrophic cardiomyopathy.